Administrative Core

CORE SUMMARY / ABSTRACT
The Administrative Core will manage the budgetary, administrative, and communication aspects of this U19. The Core
will be responsible for coordinating meetings and interactions among investigators, transmitting data, communicating
with NIH program personnel, preparing publications, and maintaining a bibliography describing work performed, and
all relative financial matters. The PI has solid expertise in managing and administering large programs from his
experiences as Director of the Massachusetts General Hospital Transplant Center and Center for Transplantation
Sciences, leading previous NIH-funded P01/U19 grants and overseeing NIH-sponsored clinical trials. The Program
Manager will act as a liaison with the hospital’s financial office, office of research affairs, and materials management.
The Administrative Core also includes a program statistician, who is available for consultation on study design,
calculation of sample size, and for analysis of data from the animal studies.